Addition of Social Needs to a Telephone-Based Developmental Care Coordination Randomized Controlled Trial in the Era of COVID

PROJECT SUMMARY/ ABSTRACT
Although universal early childhood developmental screening is recommended by the American Academy of
Pediatrics, ample evidence suggests that child health providers are not meeting those recommendations, and
many early developmental delays are being missed. Additional evidence suggests that both providers and
parents struggle to navigate the early childhood developmental system of care, with few high-risk children
actually getting referred, and fewer still ultimately receiving services. The gaps in care processes have created
gaps in evidence linking developmental screening to developmental outcomes, leading the US Preventive
Services Task Force to state that there is not enough evidence to recommend for or against universal
screening for speech and language delays or Autism Spectrum Disorders. The proposed project is a
randomized controlled trial of a telephone-based early childhood developmental care coordination system, in
partnership with 2-1-1 Los Angeles County (211LA), part of a national network of 2-1-1 call centers covering
93% of the US population. We will test the effectiveness of 211LA in increasing referrals for developmental
evaluation, increasing the numbers of children deemed eligible for services, and increasing the number of
children actually receiving interventions. The trial will enroll 662 children ages 1-3 years who receive well-
childcare at one of 10 partner clinic sites. We will conduct developmental screening on all children using the
Parental Evaluation of Developmental Status (PEDS) Online system, and randomize children 1:1 into
intervention (connection to 211LA for developmental care coordination + usual care) or control (usual care
alone, with developmental care coordination conducted by clinic staff). Primary outcomes will include referrals
to early intervention evaluations, eligibility for intervention services, and receipt of services. We will measure
these outcomes through parent report, medical record review, and 211LA data, at 6 months after enrollment.
For children with elevated developmental risk based on the PEDS Online results, we will assess development
using the PEDS: Developmental Milestones – Assessment Level (PEDS:DM-AL), conducted at baseline and
12 and 24 months after enrollment. For all children, we will administer the language subscale of the PEDS:DM-
AL at baseline, 12 months and 24 months, to evaluate development over time in the two groups. We will
measure behavioral outcomes for all children using the externalizing behavior subscale of the Child Behavior
Checklist. Expected findings include higher rates of referrals, eligibility, and receipt of intervention services
among intervention group participants, and greater developmental gains among children in the intervention
group. We will also examine the costs of the program in relation to these outcomes, to estimate the costs and
potential long-term benefits of this model. If effective, the model has the potential to disseminate rapidly
throughout the 2-1-1 network and transform developmental care coordination in the US.

Public health relevance
PROJECT NARRATIVE Few developmentally at-risk children receive indicated early intervention services, despite clear evidence of effectiveness. Our current randomized controlled trial tests whether telephone-based care coordination through 211LA, a 2-1-1 social services call center, increases receipt of developmental services for children ages 1-3 years and improves developmental outcomes 2 years later versus usual well-child care. This administrative supplement proposes to examine receipt of other well-child care-related preventive and social services relevant to developmental outcomes, given the potential utility of 211LA's telephone-based system in the COVID era.